Functional Omics Core Laboratory

The purpose of this contract is to conduct, develop, acquire, improve, implement, validate, analyze and report data from state-of-the-art high-throughput functional omics assays and approaches (e.g., genomics, epigenomics, transcriptomics, proteomics) for comprehensive characterization of immune responses in samples from in vivo or in vitro studies investigating SIV, SHIV, or HIV. The assays will primarily focus on samples from animal models for HIV, however analysis of samples from human clinical trials with HIV may be included to evaluate immunogenicity and efficacy of vaccines or other prevention strategies.